Patients decline buprenorphine from the emergency department CTN:0107 add on

Program Director/Principal Investigator (Last, First, Middle): Brady, Kathleen T
PROJECT SUMMARY (See instructions):
Why do patients decline buprenorphine from the emergency
department?: Add-on study to CTN-0107
Emergency department-initiated buprenorphine (EDIB) successfully doubles retention in treatment at
30 days when compared to referral alone. Additionally, there are significant benefits to treatment with
buprenorphine and other medications for opioid use disorder (MOUD) including significant reductions in
overdose and all-cause mortality, better retention compared to placebo or no medication increased length
of time in recovery, decreased opioid use, decreased craving, and improved social functioning. Emergency
departments (EDs) are well-suited to engage patients in buprenorphine treatment, resulting in significantly
improved ED quality of care and increased access to this life-saving treatment. Unfortunately, only a
minority of patients eligible and offered EDIB receive it.
The specific objective of this proposal is to systematically evaluate reasons why EDIB-eligible patients
with OUD decline EDIB. This study will be a qualitative study utilizing semi-structured interviews with ED
medical providers, ED staff, and patients who are deemed eligible for EDIB to evaluate provider/staff-level
and patient-level barriers and facilitators to EDIB acceptance among eligible patients. This knowledge is
imperative to public health efforts addressing the opioid epidemic, as results can be used to improve harm
reduction interventions by addressing critical gaps for ED patients with OUD.
This proposal would be the first to examine why a minority of patients eligible for EDIB accept it when it
is available and recommended. This study will provide an important initial step in better understanding
reasons for declining EDIB and informing intervention design and implementation to increase EDIB uptake.
This study can be completed rapidly and has potential to positively impact the thousands of patients with
OUD seen in EDs across the country. Our team of experts in addiction science, survey methods,
qualitative data, implementation science and emergency medicine are uniquely qualified to carry out this
proposal.
RELEVANCE (See instructions):
The proposed research will provide the foundation to address systematic problems with ED-initiated
buprenorphine programs, which will in turn improve patient engagement in evidenced-based treatments.

Public health relevance
This project is an interview study designed to understand why patients in the emergency department (ED) who are eligible to receive buprenorphine for opioid use disorder decline it. Semi-structured interviews will be conducted with ED patients eligible to receive buprenorphine as well as ED clinicians and ED staff. It is hoped that the results of this study will allow for the development of an intervention that could be used to improve acceptance of buprenorphine by these patients.